Longitudinal Antecedents of Attention Problems in Very Preterm Children: Role of Epigenetics, Executive Function, and Caregiver Psychological Distress

PROJECT SUMMARY/ABSTRACT
This K01 proposal will prepare the candidate for an independent research career studying environmental and
biological contributors to child neurodevelopmental trajectories in typically-developing and high-risk populations,
with specific expertise in human developmental behavioral epigenetics and clinically-relevant cognitive
phenotypes (e.g., inattention). Research in developmental psychopathology has been successful in identifying
risk factors for attention problems across multiple domains, including biological, cognitive, and caregiving factors.
However, a missed opportunity is the study of multiple, longitudinal trajectories of risk factors in relation to
trajectories of inattention. Specifically, there is a need to understand whether there are heterogeneous
trajectories of inattention in early childhood, particularly during the transition to formal schooling (age 5-7) when
increases in inattention are common. Further, understanding how changes in risk factors across early childhood
relate to changes in inattention across the transition to formal schooling could provide critical information
regarding modifiable targets and optimal timing for screening and intervening with high-risk children. The
proposed study will leverage existing data from two parent grants (R01HD072267; R01HD084515; NOVI study)
focused on neurodevelopmental outcomes in children born very preterm. The current study proposes to test
associations between trajectories of biological (i.e., DNA methylation), cognitive (i.e., executive function) and
caregiving (i.e., psychological distress) factors and trajectories of child inattention in a sample of children born
very preterm, a group known to be at elevated risk for attention problems. Specific aims are as follows: (1) to
characterize trajectories of inattention in very preterm children; (2) to test the contributions of biological, cognitive,
and caregiving factors to trajectories of inattention; and (3) to test how changes in biological, cognitive, and
caregiving factors relate to trajectories of inattention. The applicant’s mentorship team will scaffold completion
of the study aims and provide needed training in (1) processing and (2) analysis of high-dimensional, longitudinal
epigenetic data, (3) advanced statistical techniques for longitudinal data analysis, and (4) frameworks (e.g.,
RDOC) for studying child psychopathology. The resources and intellectual environment at the Brown Center for
the Study of Children at Risk, Women and Infant’s Hospital, and Warren Alpert Medical School of Brown
University constitute an ideal setting to launch an independent research career. This project will provide
preliminary data for a future R01 investigating how trajectories of DNA methylation are established and altered
across development (e.g., as a function of environmental risk factors) as well as grants that follow NOVI children
into later childhood. This project is aligned with NIMH strategic priorities given its focus on charting the
development of inattention in childhood, identifying risk factors and biomarkers for inattention that could serve
as novel intervention targets, and isolating sensitive periods for interventions aimed at mitigating long-term
functional impairment.

Public health relevance
PROJECT NARRATIVE While prior research has highlighted biological, cognitive, and caregiving factors that increase risk for child attention problems, the impact of trajectories of these risk factors in relation to trajectories of inattention have yet to be studied. This study examines initial levels and change in DNA methylation, executive function, and caregiver psychological distress as predictors of inattention trajectories in a sample of 568 very preterm children. The proposed training and research activities will improve understanding of the strongest individual or combined risk factors for attention problems in this high-risk population, help us identify sensitive periods at which biological, cognitive, and caregiving factors are most predictive of functional outcomes, and provide critical information regarding the optimal focus and timing for future interventions.